Clinical Core

Abstract The Clinical Core provides the Projects with data from epidemiological, neuropsychological, medical and physical measures. The Core is responsible for obtaining informed consent for participation in the EAS and for participation in the brain donation program. The Core’s primary function is characterization of EAS subjects through baseline and annual follow-up neurological and neuropsychological evaluations, including the assignment of cognitive and dementia diagnoses. The Core also conducts Consensus Case Conferences to assign clinical cognitive outcomes for each subject at each annual evaluation. Clinical outcomes assigned include: 1) Diagnosis of DSM-IV “Dementia” versus “No Dementia”; 2) for subjects with dementia, subtypes are diagnoses using standard criteria; and 3) Intermediate States of Cognitive Impairment (amnestic Mild Cognitive Impairment, non-amnestic Mild Cognitive Impairment). The Clinical Core cooperates with the Administrative Core to collect follow-up medical and neuropsychological information for study subjects no longer able to return for in-person evaluations. Data from the Clinical Core are used to determine subject eligibility for participation in Projects 1-3. Finally, the Clinical Core collects, distributes, and banks biological specimens for current and future assays.

Public health relevance
Project Narrative The Clinical Core collects epidemiological, neuropsychological and neurological data in support of Projects 1-3. These data are used to assign diagnoses, develop other outcome variables, and correlate with neuropathologic findings and Project-specific cognitive and psychosocial measures. The Clinical Core ascertains all the confounders and effect modifiers of dementia risk.